Neural mechanism underlying audio visual vocalization processing in the macaque

Project Summary/Abstract Effective communication combines auditory and visual (AV) cues in a way that supports linguistic comprehension. It is widely recognized, for example, that viewing a speaker’s face enhances speech intelligibility. The specific anatomical and physiological mechanisms by which A and V stimuli related to communication are integrated into a neural representation that can guide adaptive behavior remain elusive. In terms of anatomy, the superior temporal gyrus (STG) appears to play a prominent role in AV speech processing. In addition to being activated during auditory processing, the STG is activated by visual facial stimuli. Further, the viewing of silent lip-reading activates the STG, suggesting that the STG is involved in language processing even in the absence of auditory input. Thus, we will focus on the STG. In term of physiology, it has been hypothesized that in lower level areas, auditory inputs drive neuronal firing patterns carrying the bulk of the neural representation of verbal information, while visual inputs operate to enhance or otherwise modulate this firing, and thus the representation. This project will examine an extension of this hypothesis into the level of the STG. Because the anatomical and physiological resolution with which we can study AV integration in the normal human STG region is limited, we propose to study the processing and integration of A and V components of natural vocalizations by macaque monkeys as a model for rudimentary aspects of AV communication in humans. To this end, we use a sensory task in which monkeys are trained to discriminate between different conspecific vocalizations while undergoing intracranial recordings from the STG. Our first aim is to define the physiology of AV interactions in the STG during communication processing. Current source density (CSD) profiles (reflecting local synaptic activity) and multiunit activity (MUA) profiles (reflecting concomitant neuronal firing patterns) will be obtained from the STG for A-only, V- only, and AV components vocalizations. Based upon multisensory integration effects in low-level auditory areas, we predict that the V input will be modulatory in nature, and will modulate the excitability of ensembles of STG neurons such that the auditory input arrives when the neuron are at maximal excitability, thereby amplifying STG output. To further explore this idea, our second aim is to determine how altering AV timing impacts physiology in STG and behavioral performance. Based again on results from lower-level auditory areas, we predict that disrupting the natural (and well learned) timing of A and V components will disrupt V enhancement of A responses. Our findings will yield further insight into how the brain integrates AV stimuli into a congruent perception, and ultimately, into the mechanisms of language deficits associated with psychiatric conditions like autism and schizophrenia.

Public health relevance
Project Narrative The intelligibility of communication signals is enhanced when audio and visual signals are combined, though the neural basis for this enhancement is unclear. The goal of this proposal is to identify neural mechanisms responsible for an increased ability to discriminate between different vocalizations in monkeys with access to both audio and visual stimuli. The results may elucidate mechanisms underlying linguistic and conversational comprehension in humans, with important implications for verbal deficits observed in autism and schizophrenia.